Spatial omics to understanding HBV control in people with HIV coinfection

PROJECT SUMMARY/ABSTRACT
Hepatitis B (HBV) infects more than 200 million people worldwide and is the 10th leading cause of death
worldwide. HBV treatment with nucleoside analogs targets the suppression of viral replication, but HBV able to
persist in a reservoir of covalently closed circular (cccDNA) form during chronic infection, with the potential to
reactivate upon immune suppression, aging, or cessation of treatment. As a consequence, lifelong treatment is
required, and eradication and functional cure of the infection, the loss of surface antigen in serum testing, occurs
at a slow rate. Moreover, HBV suppression with current therapies does not eliminate the risk of liver cancer
development. HIV coinfection with HBV is common and complicates HBV outcomes, evidenced by an 18-fold
increased liver-related mortality, compared to HBV alone. Novel approaches to HBV therapy are needed,
particularly in people with HBV/HIV. While HIV accelerates the HBV clinical course, it also presents unique
scientific opportunities as shortly after starting HBV-active antiretroviral therapy (ART), some people with
HBV/HIV experience higher rates of HBsAg loss, 5 times what is seen in HBV alone. Leveraging an established
clinical cohort with HBV/HIV and HBV in Zambia, we will analyze the impact of HIV-related immune suppression
and restoration with ART on HBV liver reservoir and the liver microenvironment using cutting-edge spatial
proteomic and transcriptomic technologies. These technologies, which are capable of delineating RNA, DNA,
and protein targets without cellular or tissue dissociation at subcellular resolution, will be applied to liver biopsies
from cohort participants before and during therapy, allowing us to investigate and determine cellular composition,
HBV- and HIV-infected cells, spatial architecture, and the hepatic microenvironment. The resulting data will
advance the development of HBV cure, particularly for people with HIV, by identifying how HIV accelerates liver
pathogenesis, whether these mechanisms are normalized with ART, and virus-host interactions in the liver that
mediate HBV control including FC. This line of research will validate current mechanisms being evaluated in
trials and pave the way for new and emerging immunotherapies for HBV cure.

Public health relevance
PROJECT NARRATIVE Hepatitis B virus is a highly successful human pathogen, with 300 million chronic infections and is the 10th leading cause of death worldwide. We will deploy cutting-edge spatial protein and RNA imaging technologies capable of visualizing RNA, DNA, and protein targets without disrupting the tissue at subcellular resolution allowing the investigation and determination of the cellular composition, HBV and HIV infected cells, spatial architecture, and the hepatic microenvironment of the human liver of people living with HBV/HIV and HBV alone. The results of this proposal will help identify the critical factors required for HBV clearance as well as the molecular hurdles impeding clearance, particularly in people living with HBV and HIV, offering new therapeutic targets for HBV cure.